ALPHA INTERFERON WITH DDI FOR PATIENTS WITH KAPOSI'S SARCOMA

ACTG 206; a randomized phase II trial to determine the safety, tolerance and efficacy of two doses of interferon alpha combined with didanosine in patients with Kaposi's sarcoma.